Core A: Administrative Core

The overall goal of the Penn Center for the Study of Epigenetics in Reproduction (PennCSER)
is to investigate the role of epigenetic gene regulation in reproduction, with a specific emphasis
on gametogenesis and early development as they pertain to normal development, implantation
and placentation, infertility and Assisted Reproductive Technologies (ART). The Administrative
Core will facilitate the successful pursuit of each of the individual projects and enable
collaboration among projects. The Core will also organize the solicitation and selection of pilot
projects that complement the existing Center program. Finally, the Core will support the
Outreach Activities, facilitate training, engage new investigators with an interest in reproduction
and assist interactions with the NCTRI network, as well as the internal and external review
process.